Center for Childhood Obesity Prevention - Metabolism and Bioenergetics Core

PROJECT SUMMARY
The Metabolism and Bioenergetics Core (MBC) is a critical research core in the Center for Childhood Obesity
Prevention (CCOP). The MBC make cutting-edge biomedical research services available to CCOP
investigators at Arkansas Children’s Research Institute (ACRI). Our specific expertise and focus are the
application of stable isotope technologies and high resolution respirometry to the study of substrate
metabolism and bioenergetics. The primary goal of the MBC is to support early stage CCOP investigators in
research focused on the development, treatment, and prevention of obesity by providing access to
instrumentation and expertise to execute studies focused on altered metabolism and bioenergetics. This
encompasses study design, implementation, biological sample analyses, as well as data analyses and
interpretation. The MBC will further mentor investigators in key methodological approaches used to quantify
metabolism and bioenergetics. Our long-term goal is to transition the MBC into a sustainable core facility at
ACRI with broad intra- and extra-institutional user base.